Phenotypic Driven Growth Trajectories in Very Preterm Infants to Define Nutritionally Mediated Health Outcomes and Modifiable Targets

PROJECT SUMMARY
Very preterm infant growth patterns are linked to neurodevelopmental and health outcomes, yet, ideal growth
pattern trajectories have not been established as a means to guide nutritional intervention for this population.
With the majority of very preterm infants exhibiting growth below the expected fetal or infant trajectory, greater
characterization of very preterm infant growth is an essential step to elucidate the role of nutrition in the care
and development of preterm infants. The overarching objective is to identify very preterm infant growth patterns
prior to term age and across the first year of life that are phenotypically-defined (maternal, infant, and
environmental factors including social determinants of health) and determine the impact of the phenotypically-
informed growth patterns on very preterm infant neurodevelopmental and health outcomes. We hypothesize
that phenotypic-derived latent class growth analysis-derived curves encompassing clinical and environmental
exposures across the continuum of the neonatal intensive care unit (NICU) and post-discharge periods will
identify growth patterns predictive of outcomes. To investigate this hypothesis, patterns of growth will be
classified for two sentinel epochs spanning birth to 36 weeks' gestational age (the NICU period) and birth to 12
months' corrected age (infancy). Through a detailed collection of maternal and infant health, social and
environmental determinants of health, nutrient intake, and body composition; the very preterm infant exposures
differentially represented in these phenotypically-informed growth patterns will be identified. Subsequently, the
impact of these phenotypically-informed growth patterns on neurodevelopmental and health outcomes will be
determined. Lastly, a repository of longitudinally-collected biologic samples through the first two years of age
will be established to foster a deeper exploration of the metabolic processes related to the identified
phenotypes. This examination will be the first to bridge the NICU and post-hospital discharge epochs to
investigate growth trajectory without predetermined expectations and informed by extensive nutrition, health,
and social data. Through this investigation of phenotypically-defined growth patterns, the modifiable factors
influencing growth trajectory and its link to very preterm infant outcomes will be revealed to inform both clinical
care and future interventional trials to optimize nutrition and growth for each very preterm infant.

Public health relevance
PROJECT NARRATIVE This is relevant to public health because it seeks to identify modifiable factors in very preterm infant growth, nutrition, social and environmental exposures, and illness to optimize long-term abilities and health outcomes. The established link between very preterm infant growth and neurodevelopmental outcomes likely represents a combination of nutrient intake, illness prevention, and social support that promotes growth and brain development. Up to 30% of very preterm infants continue to experience motor, learning, behavior problems, and/or cognitive impairment; identifying opportunities for positive interventions is critical to ensuring these infants have every opportunity for an optimal life.